Administrative Core

ADMINISTRATIVE CORE - ABSTRACT
The “UTMB-Novartis Alliance for Pandemic Preparedness (UNAPP)” combines UTMB’s excellence in virology
& BSL4/3 facility with Novartis’ power in drug discovery & development to deliver pandemic antivirals. The
Administrative Core provides the leadership and programmatic coordination required to fully realize the impact
of this unique academic-industry partnership and meet the goals of the Antiviral Drug Discovery Centers for
Pathogens of Pandemics Concern. We will accomplish this through the following four aims: i. implement an
integrated organizational governance and programmatic structure that will promote a team science approach to
antiviral drug discovery for pandemic prevention against Coronaviruses, Flaviviruses, and Henipaviruses; ii.
provide integrated decision making in scientific, operational, financial, intellectual property protection and
communication through cohesive and collaborative governance; iii. implement a Developmental Research
Project program that will expand the center's scope and range of research while encouraging outside
investigators to develop novel technology and innovative research ideas in antiviral drug discovery; and iv.
implement a Mentored Project program designed to increase the availability of qualified early career researchers
in antiviral discovery research by providing career development and mentored research to further their
professional advancement.